CAR T platform to treat solid tumors

SUMMARY
Cancer is one of the leading causes of death worldwide. Over the years, several treatment approaches have
been developed. However, their effectiveness is severely limited by the heterogeneity of cancer cells. Thus,
there is a constant need for development of therapeutic approaches with improved outcome, such as
immunotherapy that utilizes and enhances the normal capacity of the patient's immune system. Of note, renal
cell carcinoma and ovarian cancer are considered immunogenic, or “hot” cancers, in that tumors are infiltrated
with T cells. This provides optimism that the immune system can be harnessed to be a potent and durable
weapon against these cancers.
Chimeric antigen receptor (CAR) T cell therapy has shown remarkable efficacy against hematologic tumors. Yet,
CAR T cells fail against solid tumors due to key obstacles presented by the tumor microenvironment (TME). We
propose in this application to demonstrate proof-of-concept of a novel platform that can overcome the current
barrier to CAR T cell therapy in solid tumors. Our strategy combines the specificity of anti-TIM1 CAR with
modulation of the TME by a combination of two cytokines, leading to a shift from immunosuppressive to a
cytotoxic environment. Our approach capitalizes on the recruitment and activation of a broad repertoire of
endogenous innate and adaptive immune cells, including tumor-specific T cells. Super2 and IL-33 CAR T cells
promote antitumor immunity in multiple murine solid tumor models and is impervious to antigen loss, highlighting
its potential as a universal CAR T cell platform for treatment of solid tumors. Aims will include the following: Aim
1. Design and evaluate human constructs expressing anti-TIM1 CAR, Super2 and IL-33 in vitro. Aim 2.
Demonstrate proof of concept (POC) of efficacy of a dual cytokine delivery by anti-TIM1 CAR T cells in a
humanized model of Renal cell carcinoma (RCC).

Public health relevance
NARRATIVE Much progress has been made in the dosing and scheduling optimization of conventional chemotherapy to maximize their effectiveness. Despite this, many solid tumors including ovarian and renal cell carcinomas, especially those diagnosed at advanced stages, progress and become refractory to treatment. Ovarian cancer and renal cell carcinomas are especially difficult cancers to treat in advanced stages as evidenced by a combined annual mortality of ~30,000 patients in the United States each year. We propose to develop and characterize a chimeric antigen receptor (CAR) T cell platform that overcomes the barriers created by solid tumors resulting in superior efficacy of target-directed therapies.